L-2-Hydroxyglutarate and Metabolic Remodeling in Hypoxia

Project Summary. Cellular hypoxia-reoxygenation or organ ischemia-reperfusion promotes intracellular
redox stress, which can lead to cellular dysfunction and injury through the generation of reactive oxygen
species (ROS). In prior work, we identified the role of L(S)-2-hydroxyglutarate (L2HG) as a unique
metabolic derivative of α-ketoglutarate (2-oxoglutarate, or 2OG) that increases in hypoxia or ischemia. In
the ongoing cycle of this award, we have shown that L2HG decreases glycolysis and increases pentose-
phosphate pathway (PPP) activity as a unique mechanism for promoting redox protection in endothelial
cells and in the myocardium. In this next proposed four-year cycle, we turn our attention to the
relationship between L2HG and branched-chain ketoacids (BCKAs), metabolic derivatives of branched-
chain amino acids (BCAAs), and their role in redox protection in the heart. Upon examination of the
metabolome in hypoxic cardiovascular cells, we observed that BCKAs are significantly increased
compared with normoxic cells, and that this increase in the BCKA pool is also an important determinant of
redox protection. Abundant preliminary data provided in this application demonstrate that the redox
protection afforded by BCKAs is mediated by Hif-1α stabilization, and comes about by a unique
mechanism: an increase in BCKAs leads to an increase in BCAAs, which is associated with an increase
in 2OG generation from glutamate via reamination of BCKAs. The increase in 2OG in the reductive
environment of hypoxia leads to an increase in L2HG, with accompanying redox-protective metabolic
reprogramming. Thus, the central hypothesis of this proposal is that an hypoxia-induced accumulation of
BCKAs in endothelial cells (ECs) and cardiomyocytes (CM) increases L2HG, which together promote
redox protection. To test this hypothesis, we propose three specific aims: 1) we will determine the effects
of hypoxia on BCAA and BCKA metabolism in ECs and CMs; 2) we will identify the molecular and
metabolic determinants linking BCKA metabolism with L2HG generation, and their consequences for Hif
stabilization in ECs and CMs; and 3) we will study the effects of the BCKA-L2HG metabolic axis in
hypoxia or ischemia on redox protection and function in ECs, CMs, and the myocardium. The results of
these studies should provide useful insight into the complex interplay of metabolic intermediates that
govern redox potential and redox protection in the myocardium, and its potential consequences for
ischemia-mediated cardiovascular diseases.

Public health relevance
Project Narrative The proposed research is relevant to a number of cardiovascular (CV) diseases that affect the public health, including coronary heart disease. Specifically, we plan to focus on a unique set of metabolites that interact to protect the CV system from injury during (transient) oxygen deprivation that occurs, for example, during heart attacks. We will study the effects of these unique metabolites on vascular (endothelial) and cardiac (cardiomyocyte) function with the hope that we can ultimately identify potential novel metabolic therapies that can prevent or treat this common CV pathobiology and reduce its morbidity and mortality.